Admin Core

Abstract Meharry Medical College (MMC) is a Historically Black College/University located in Nashville Tennessee and the first medical school for African Americans in the South. It has a School of Medicine, School of Dentistry, and School of Graduate Studies & Research. In February 2021, it established a new fourth school, the School of Applied Computational Sciences (SACS), to provide academic training in data science and computing-related research on a variety of areas including medical, social, and environmental issues and trends that impact the health of minority and underserved populations. The Research Centers in Minority Institutions (RCMI) Program at MMC (in Health Disparities Research, RHDR@MMC) is a long-term NIMHD- funded endeavor that enables high quality basic, behavioral, and clinical research to eliminate health disparities. Our RCMI U54 grant supports health disparities research in many diseases including cardiovascular diseases, cancer, diabetes, HIV/AIDS and neurological diseases that disproportionally affect non-Hispanic Black population in the US. With the great potential of data science to transform industries, health care, and scientific discovery, this administrative supplement seeks to enhance the data science capacity of the RHDR@MMC program and foster collaborations between RCMI researchers and data scientists, to enable the RCMI investigators to assess and analyze big health sciences data to enhance the overall productivity of the RCMI program as well as contribute to addressing health disparities. Specifically, this supplement award will help create a data science task force for this project, identify data science needs of the RCMI researchers at Meharry, and foster collaborations between them and the data science experts in SACS which will include the development of a joint RCMI/SACS Workshop. This will enable SACS to provide RCMI researchers with much needed data science expertise and resources for study design, data infrastructure, data collection, data engineering, health informatics, and machine learning techniques, to enhance research outcome as well as the cooperation among investigators from different domains. It will enable the RCMI researchers of all levels to better address the challenges in their health disparities research. With this award, we expect that the RHDR@MMC program will be greatly empowered to advance research on minority health and health disparities.

Public health relevance
This administrative supplement will help the data scientists in the School of Applied Computational Sciences at Meharry Medical College understand and address the computing needs of the RCMI researchers at Meharry and, hence, foster the collaborations between them. In addition, the data science training enabled by the supplement award, small collaborative research groups created, and summer research support for graduate students will substantially enhance the data analytics skills of the RCMI investigators, staff, medical residents, and graduate students at Meharry. Moreover, by enabling efforts to create and deliver data sets, platforms, research collaboration, and targeted educational modules, this project will facilitate the RCMI investigators to assess and analyze big health sciences data to enhance the overall productivity of the RCMI program as well as contribute to addressing health disparities.